Controlling drug crystallization, polymorphism, and physicochemical properties using mechanochemistry

Project Summary
Our research program focuses on understanding the relationship between the structure and function of organic
solid-state materials. We are especially interested in understanding this relationship in the context of drug
polymorphism, physicochemical properties, and crystallization mechanisms. Crystallization and structural
determination are exceptionally important aspects of chemical synthesis, biochemistry, and pharmaceutics.
While many compounds can be crystallized through standard techniques, some compounds such as oils, chiral
compounds, and natural products are difficult to crystallize. Two additional challenges that arise when developing
drug molecules include polymorphism and poor physicochemical properties (e.g., aqueous solubility).
Polymorphism is the ability of a compound to exist in more than one form or crystal structure, and polymorphs
often exhibit different properties. Poor aqueous solubility impacts bioavailability and causes many drugs to be
rejected during discovery. Our group has taken a multifaceted approach toward addressing the structure-function
relationship by using cocrystallization, mechanochemistry, and structural analysis as strategies for controlling
and tuning behaviors of drug molecules. Cocrystallization involves combining at least two compounds into a
unique solid phase, and the components typically interact through noncovalent bonds. Mechanochemistry is a
chemical transformation that is either initiated or sustained by mechanical force, and the field has undergone a
rapid re-emergence because it is a green technique and has shown promise in controlling polymorphism.
Cocrystallization and mechanochemistry offer our group platforms for preparing pharmaceutical materials of
interest, while interrogating how the resulting structure gives rise to drug function. Our laboratory recently
developed a mechanochemical method to facilitate crystallization of beta blocker drugs that otherwise form oils
when standard crystallization methods are used. We have also used cocrystallization to improve aqueous
solubility of a biopharmaceutics classification system (BCS) Class II (low solubility) antibiotic while maintaining
drug safety. Most recently, we demonstrated that mechanical methods can be used to reversibly interconvert
pharmaceutical polymorphs. Over the next five years, our goals are to use mechanochemistry to control
crystallization and polymorphism of drug molecules, elucidate mechanisms by which mechanochemistry
facilitates such crystallization, and determine structural characteristics that afford enhanced physicochemical
properties in BCS Class II and IV drugs. The methods outlined above will be complemented with several
characterization techniques to determine how structural modification impacts drug behavior. Our long-term goal
is to use the insight gained from this work to enhance our understanding of the crystallization process, develop
novel strategies for synthesizing pharmaceutical solids with improved treatment efficacy, and address
fundamental challenges in controlling drug polymorphism. Overall, we aim to impact the future of disease
treatments by determining the role that the solid-state structure plays in drug function and efficacy.

Public health relevance
Project Narrative Our research program uses a combination of synthetic and characterization methods to understand how the solid-state structure of drug molecules leads to function. The drugs we investigate typically exhibit non-ideal properties or controlling their solid form is challenging. By understanding the influence of solid-state structure on function, our research program will develop strategies for controlling or modifying structures and enhancing drug properties as a path toward improving disease treatments.